Studies in the Synthesis of Physiologically Important Natural Products

This application describes the development, progress, and future directions of several projects dedicated to the synthesis of physiologically important natural products, as well as the investigation of an interesting reaction discovered through these efforts. The primary goals of each project are the development and application of methods to complete the synthesis of the desired targets. The current strategies for the synthesis of these targets have been designed to be amenable to the incorporation of alternative functionality for the development of analogs, which will be subjected to biological screening to identify novel or interesting physiological activity

Public health relevance
Apart from being synthetically challenging, the targets described herein display interesting physiological properties including activity towards antibiotic resistant bacteria, inhibition of enzymes that suppress blood clot removal from blood vessels, and possible therapy for high blood pressure and cancer. It is therefore not surprising that development of new therapeutic agents that are capable of ameliorating the detrimental effects of these disease states are of importance to public health and have generated considerable interest and investigation in the medical community.